Clinical and public health research training in oral health for Southeast Asia

ABSTRACT
Oral diseases pose a major health challenge globally and affect people throughout their lifetime. These diseases
share common risk factors with other major Chronic Non-communicable Diseases and Disorders (NCDs). The
well-established oral-systemic health connections also indicate that prevention and treatment of oral diseases is
a critical component in maintaining good general health and well-being. Yet, due to the lack of personnel, access
to training, knowledge of research methods, and funding, oral health care and research is still limited in Southeast
Asia. The large diversities in the geography, social structure and cultures in Southeast Asian nations emphasize
the need for locally relevant research to identify risk factors and oral health management strategies that would
be effective in each country. The goal of this application is to sustainably strengthen the oral health research
capacity among LMICs in Southeast Asia by establishing a training hub in Thailand and fostering a network of
regional researchers. The plan proposes to build upon and expand two established training programs “Clinical,
Public Health, and Behavioral Oral Health Research Training for Thailand” (D43TW007768 and D43TW009071,
PI: DeRouen), which have been collaborative efforts between the University of Washington School of Dentistry
(UW) and affiliated Faculties of Dentistry at Khon Kaen University (KKU) and Thammasat University (TU) in
Thailand. Dr. Waranuch Pitiphat, Dean of KKU Faculty of Dentistry, the Director of this Program (PD) was a
major collaborator and Associate Director of the previous training programs. The proposed program will also
include 4 major collaborating institutions: University of Indonesia, University of Malaya, University of Philippines
Manila, and Can Tho University of Medicine and Pharmacy in Vietnam. Five levels of training are being
proposed: (1) Short-term training. A series of 5-day workshops on clinical research methods, conducted in
Thailand or other Southeast Asian countries annually (n=120 total); (2) Intermediate-term training. An 8-week
program at the UW COHO Institute in Clinical Research Methods in Seattle. The trainees will participate in the
program online for 6 weeks and in Seattle for 2 weeks (n=18 total); (3) Medium-term training. A Short Course
Training in Research Methodology & Biostatistics offered annually at KKU in Thailand. This is an intensive
program in which the trainees will take didactic courses and develop an individual research proposal at the end
of the 4-month course (n=20 total). Medium-term trainees can apply for the next level of training; (4) Non-degree
research training. A research fellowship program allows the trainees to do research in home country under
guidance of a local mentor as well as UW and Thai faculty (n=16 total); (5) Long-term training. The program
will support five dentists from Southeast Asia to pursue PhD in Oral Sciences at the two Thai universities. After
completing 1-year coursework in Thailand, PhD students will attend the Summer Institute in Seattle and work
with UW mentors to develop a dissertation research proposal to be carried out in their home country.

Public health relevance
Project Narrative Southeast Asia has over 600 million people, most of whom reside in low and middle-income countries that have a high burden of oral diseases which adversely impacts non-communicable diseases (e.g. diabetes and cardiovascular diseases), child development, and quality of life. There is a clear need for local research to identify risk factors and effective oral health management strategies in Southeast Asian countries, but the lack of personnel and access to training in research methods has been a major impediment to research in the region. We will build a sustainable, effective, and efficient clinical research methods training program by establishing a training hub in Thailand and by forming a regional network of oral health researchers who will conduct quality, locally-relevant research that will contribute to better management of this important public health problem for the benefits of the Southeast Asia.